Hierarchical Onset of Germ Layer Specification

Summary. During early development, specification of the three primordial germ layers, ectoderm, mesoderm,
and endoderm, is the first major step in defining embryonic tissues, and dysregulation of this process leads to
developmental defects. Germ layer formation is a fundamental focus of developmental biology; however, little is
known about an emerging concept that the initiation of their expression follows a temporal hierarchy. The
ordering is debated in different embryonic models and importantly it is not known whether proper coordination of
timing is essential for development. The cell differentiation that accompanies germ layer formation largely occurs
in gastrulation. Yet, many tissue-specific genes that specify individual germ layers initiate their expression in
blastula stages following genome activation, requiring methods to track the onset of their nascent transcription.
We developed a new method for quantifying the blastula nascent transcriptome using 5-ethynyl uridine (EU)
incorporation and isolation, termed EU-RNA-seq. This method has increased sensitivity relative to conventional
RNA-seq and enables delicate measurement of time-of-onset for maternal-zygotic transcripts. By analyzing germ
layer expression in the model vertebrate Xenopus laevis, we discovered that the ectoderm genes are expressed
earlier than endoderm genes, suggesting a hierarchical onset of germ layer expression that is consistent with
recent observations made in mouse. However, the mechanisms underlying the hierarchical onset of germ layer
expression remain largely unknown. Interestingly, the phased onset is consistent with our recent finding that
large-scale zygotic transcription initiates in a spatially graded manner, first in cells at the animal pole (AP, the
presumptive ectoderm) and delayed in cells at the vegetal pole (VP, the presumptive endoderm) in blastula
embryos. Epigenetic regulation, including chromatin accessibility and histone modifications, have been shown
to play a central role in gene regulation in early development. We hypothesize that differential epigenetic
regulation may underlie these patterns of genome activation and differential timing of germ layer induction. We
found a strong positive correlation between nascent transcription and transcription factor binding sites (TFBS)
enrichment for pioneer factors FOXA4 and POU3F1 and a negative correlation with the histone demethylase
KDM2B. To gain deeper mechanistic insights into the origin of hierarchical germ layer initiation, we aim to probe
chromatin accessibility in distinct regions for the presumptive germ layers in the blastula embryos and determine
binding of FOXA4 and POU3F1. Moreover, to understand the developmental consequences of dysregulated
germ layer timing, we implemented an approach to spatially alter cell division timing and alter the pattern of
genome activation in blastula embryos. We will characterize the timing of germ layer gene expression programs
in the desynchronized embryos and determine the phenotypes of gastrula development. Uncovering the
mechanisms of hierarchical germ layer expression and its functional importance will provide new insights into
our understanding the first events in cell fate decisions and tissue specification in early development.

Public health relevance
Relevance. Normal early embryo development requires the differentiation of pluripotent cells into three primary germ layers, ectoderm, mesoderm, and endoderm, that form specific tissues and organs in later development. An emerging concept is that the germ layer specification initiates in a hierarchy although the mechanisms underlying this process and the functional importance for embryogenesis are unknown. By regionally characterizing the nascent transcriptome and chromatin accessibility and through manipulation of germ layer expression hierarchy, we will uncover new insights on the earliest cell fate decisions in development.